Administrative and Analytical Core

The purpose of the ADMINISTRATIVE AND ANALYTICAL CORE is to provide infrastructure for the P01, which will ensure the completion of the proposed studies and coordination of all P01 activities. Data analysis, data sharing, and integration among Projects will be organized through this Core. Core A is the principal organizational component through which the P01 Directors and Project Directors will execute their responsibilities. This Core provides administration and leadership, scientific, and fiscal oversight by performing grant management functions that are essential to the proposed research. Core A works with the P01 Team to provide direction and ensure the quality of the research toward the proposed aims. This Core ensures training and regulatory compliance and the production of subjects for this P01. Core A serves as liaison to NIH staff and the external advisory board. In addition, this Core will work with the Team to communicate, disseminate, and translate the findings and methodologies from the P01 to the broader scientific community, to include presentations, publications, organization of training opportunities, and workshops.

Public health relevance
This Core is the principal organizational component through which the P01 Directors and Project Directors will execute their responsibilities. It is critical to the project by serving to provide infrastructure and integration among the activities of the P01 and support for data management and analysis. This Core serves the general needs of the projects.